Role of novel projection-defined basal amygdala subregions in fear memory expression

PROJECT SUMMARY/ABSTRACT
The basal amygdala (BA) has been shown to be involved in valence-specific behaviors, including fear learning
and reward behaviors. These behaviors are linked not only to genetic, anatomical, morphological, and
electrophysiological characteristics of the BA, but also the various inputs and outputs of the BA. Current research
has revealed the presence of four novel projection-defined subregions within the BA, each with unique brain
connections that can underlie their function. Understanding learning and memory associated with the BA is
especially important considering how dysregulation of tightly regulated emotional behaviors and associations
can contribute to anxiety, depression, and PTSD. Therefore, understanding how information flows through the
BA and its subregions along with the involvement of neuronal projections coming in and out of the BA is
necessary to understand these disorders.
This proposal combines brain-wide activity mapping along with in vivo calcium activity recording and neuronal
manipulation to test the role of projection-defined BA subregions in the retrieval of fear and fear extinction
memories. Recent advances in the characterization of BA regional connectivity will be employed to examine
neuronal activity within each of the four BA subregions’ connectomes using a mouse model that can label active
neurons brain-wide (Aim 1A). Next, retrogradely labeled subpopulations unique for each of the four BA
subregions will be subjected to in vivo calcium activity recordings (Aim 1B) and optogenetic manipulations (Aim
2). Collectively, these aims will provide information on the correlative activity of direct inputs and outputs into and
stemming from each BA subregion, activity of each BA subregion in valence-specific behaviors with particular
attention to fear and extinction memories, and possible causal contributions of each BA subregion neuronal
activity to fear and extinction memory expression.
For successful completion of this project, the applicant will be thoroughly trained in brain-wide imaging of
neuronal activity, fiber photometry, and optogenetic manipulations. In addition, the applicant will be provided with
numerous opportunities for training in science communication, mentorship, and career exploration. The Reijmers
and Maguire labs at Tufts University foster an environment where the applicant will be intellectually engaged and
supported with all necessary facility, equipment, and guiding to ensure productive graduate training, and to
prepare the applicant for a flourishing career as an independent researcher in neuroscience.

Public health relevance
PROJECT NARRATIVE The basal amygdala (BA) is important for valence-specific behaviors such as the recall of aversive memories. Understanding learning and memory associated with the BA is especially important considering how dysregulation of tightly regulated emotional behaviors and associations can contribute to anxiety, depression, and PTSD. This proposal aims to dissect the role of novel projection-defined subregions within the BA in the retrieval of fear and extinction memories, which will provide valuable insights into BA spatial and functional organization.